Longitudinal assessment of the role of interoception in chemotherapy-induced peripheral neuropathy (CIPN) along the cancer chemotherapy continuum

PROJECT SUMMARY/ABSTRACT
Chemotherapy-induced peripheral neuropathy (CIPN) is a severe dose-limiting toxicity that affects over 65% of
patients receiving taxane- or platinum-based chemotherapy for breast or gastrointestinal cancers. Not only does
CIPN increase mortality by limiting the dose of chemotherapy, CIPN affects walking, writing, eating, and dressing
via numbness, tingling, pain, cold sensitivity, and cramping in the hands and feet. There are no FDA-approved
treatments for CIPN because we need a greater understanding of the pathophysiology of CIPN in humans. This
project is motivated by an innovative perspective that CIPN symptoms are not due simply to peripheral nerve
damage, but rather that CIPN symptoms are worsened by changes in the brain, including interoception—the
brain’s processing of sensations from the body.
This is an observational longitudinal cohort study in 120 patients with breast or gastrointestinal cancer scheduled
to receive taxane or platinum chemotherapy along with 60 age-matched healthy controls. The patients will be
assessed within 2 weeks before starting chemotherapy, less than one month after completing chemotherapy,
and six months after completing chemotherapy. Controls will be assessed at matched time intervals. Each
assessment will include (1) measures of neural substrates of interoception (a brain MRI scanning session), (2)
patient-reported and clinical features of interoception and peripheral nerve function, and (3) patient-reported
CIPN severity. Our aims are to assess changes in interoception along the cancer chemotherapy continuum
compared to healthy controls, and to assess the relationships between interoception and CIPN in patients.
This is the first study assessing interoception before and after chemotherapy compared to healthy controls, let
alone how interoception contributes to CIPN: a common, severe, dose-limiting toxicity with enigmatic
mechanisms. By including taxane- and platinum-induced CIPN we can address two common neurotoxic agents
that exhibit distinct signs, symptoms, and mechanisms of toxicities, and may respond differently to a given
treatment. Our results will inform our novel theoretical framework that CIPN is related to interoception, thereby
informing a follow-up clinical trial using interoception-based biomarkers, prophylactics, or treatments for CIPN
for example using exercise, meditation, or pharmacological agents. This work will ultimately help alleviate the
burden of chemotherapy on patients with cancer.

Public health relevance
PROJECT NARRATIVE Over half of all patients receiving taxane- or platinum-based chemotherapy for breast or gastrointestinal cancers experience a dose-limiting toxicity called chemotherapy-induced peripheral neuropathy (CIPN), which can involve numbness, tingling, pain, and sensitivity to cold in the hands and feet. There are few effective treatments for CIPN because the development of CIPN in humans is not well understood. This project will learn more about how the brain’s processing of bodily sensations might play a role in CIPN to inform new biomarkers and treatments for CIPN that will help alleviate the burden of chemotherapy on patients with cancer.